Lung Transplant Consortium - Data Coordinating Center

ABSTRACT
Lung transplantation is an effective and life-extending treatment for patients with advanced lung diseases.
However, improvements are needed in donor management, candidate selection, and recipient care to prevent
early postoperative complications and improve the long-term success of lung transplantation. To address these
unmet needs, the NHLBI is creating the multisite Lung Transplant Consortium (LTC) to conduct clinical and
mechanistic observational research across up to 8 clinical centers (CCs) and up to 24 individual sites. Central to
the success of the LTC is a single Data Coordinating Center (DCC) that will oversee consortium wide activities
including the development and implementation of a common protocol that will enroll approximately 3200 lung
transplant subjects prospectively collecting clinical data and serial biosamples to create a unique resource for
future research. With this application, the Duke Clinical Research Institute (DCRI), proposes to serve as the
administrative and operational home for the LTC DCC, partnering with the biorepository expertise and resources
of the University of Pennsylvania (Penn). The DCRI-Penn DCC brings unparalleled clinical lung transplant
subject matter expertise, longstanding prior experience coordinating multicenter research studies in lung
transplantation, and operational rigor in research oversight and biosample collection that will fully support and
enhance the LTC committee structure, common protocol design and implementation, and CC studies. The DCC
will be led by the Multiple Principal Investigator team of Drs. Palmer, Christie, and Neely, who together bring
considerable and complementary expertise in clinical and research aspects of lung transplant, data and statistical
methodology, leadership experience in the design, coordination, and publication of multicenter research studies
in lung transplant and lung diseases. The DCRI-Penn DCC team comprises additional experts in transplant
surgery, data management, regulatory affairs, site-based research oversight and monitoring, digital health,
patient engagement, web design and communication. Thus, the DCC team is optimally poised to collaboratively
partner with the NHLBI and CCs to complete the following Aims: 1) create LTC administrative infrastructure that
facilities efficient team communication, timely dissemination of study results and data, and public engagement,
including creation and maintenance of the LTC website that serves as a focal point for protected consortium
communication and engagement of the broader lung transplant community and key stakeholders 2) provide
thought leadership and operational input that ensures the efficient development of high-impact, operationally
feasible, and scientifically rigorous common protocol and CC studies, 3) oversee common protocol conduct
including use of a single IRB, site operations, robust collection of serial subject data and biosamples, monitoring
of data quality, and safety reporting in a manner that results in timely subject enrollment and ensures the rigor,
quality, and completeness of clinical data and biosamples.

Public health relevance
Well-designed multicenter research is urgently needed in lung transplant to optimize donor management, improve recipient candidate selection, reduce postoperative complications, and ultimately extend long-term patient survival. The Lung Transplant Consortium (LTC) will fill these knowledge gaps through the conduct of clinical and mechanistic observational studies across up to eight Clinical Centers (CCs) and through a common protocol led by a single Data Coordinating Center (DCC). The Duke Clinical Research Institute partnered with the University of Pennsylvania as the LTC DCC will provide the consortium with outstanding scientific leadership, experienced administrative support, operational excellence, and biobanking infrastructure to ensure the development and conduct of rigorous, impactful, and efficient studies.